ENDOTHELIUM IN CARDIOVASCULAR FUNCTION

This is an application for partial funding of the third conference on Endothelium and Cardiovascular Function to be held under the auspices of the Federation of American Societies for experimental Biology (FASEB), from June 26, 1994, in Copper Mountain, Colorado. Participation will be limited to 200 scientist (including the speakers and discussion leaders), who will be selected on the basis of their expertise and interests as most likely to contribute to a stimulating and productive environment. The meeting, for the third time, will focus on the role of the endothelium in interacting with the blood and modulating the responsiveness of the underlying vascular smooth muscle in health and disease. The conference will consist of nine scientific sessions, each with four to six speakers and a discussion leader; all will be investigators with wide experience in the endothelium and its functions. In addition, a poster session will be held daily, which will allow more junior participants to present their data and discuss them with the authorities in the field. The central theme will be ability of the endothelium to alter the amounts of anti-adhesive, anti-aggregatory, anti-inflammatory and vasoactive factors made available to the blood components and/or to the underlying vascular smooth muscle. These discussions will permit the understanding of the true role of the endothelial cells in modulation the fluidity of the blood and local vasomotor responses under normal and pathological conditions. They will be key to determining the contribution of endothelium-dependent phenomena in the etiology of a variety of cardiovascular dysfunctions, and hence, provide insight into their rational treatment.